Functional dynamics of essential bacterial proteins and EPR technology development

Project Summary/Abstract
Proteins are vital to all biological processes, driving cellular functions and dysfunctions that directly affect human
health. Detailed knowledge of protein structure and dynamics is critical to understanding their function so that
effective and directed therapeutics can be developed to improve human health. For example, society is in dire
need of novel antibiotics against drug-resistant bacteria. This proposal integrates my expertise in and current
research on protein structure and functional dynamics related to antibiotic resistance in Gram-negative and
Gram-positive bacteria and the development of transformative electron paramagnetic resonance (EPR)
spectroscopy technologies for biomedically relevant structural biology applications. The lipopolysaccharide
(LPS) transport (Lpt) system of Gram-negative bacteria features tempting new drug targets against important
pathogens such as Escherichia coli, Salmonella typhimurium, and Vibrio cholera. The periplasmic structures of
the Lpt proteins are particularly attractive as potential antibiotic targets due to their critical role in the essential
LPS transport process, their unique structural fold (no mammalian proteins have yet been identified as having
this fold; thus, drugs aimed at this structure would be specific and effective antibiotics against Gram-negative
pathogens), and their need to dock with each other at structurally homologous interfaces (drugs disrupting these
unique protein–protein interactions result in cell death). Similarly, a better understanding of antibiotic-resistant
enterococci such as Enterococcus faecalis, which are intestinal microbes that normally coexist within their host
yet are one of the most common causes of hospital-acquired infections after treatment with antibiotics such as
cephalosporins, is critical to developing novel strategies to prevent or treat multidrug-resistant enterococci.
Furthermore, development of advanced instrumentation technologies such as EPR spectroscopy that are ideally
suited to the study of detailed representations of protein structure and functional dynamics is essential to
understanding protein function across the entire scope of human health and disease.

Public health relevance
Project Narrative Detailed knowledge of the structure and dynamics of proteins, which are vital to all biological processes and drive cellular functions and dysfunctions that directly affect human health, is critical to understanding their function so that effective and directed therapeutics can be developed to improve human health. The specific focus of this research is to use an array of biophysical, computational, and microbiological approaches to obtain a better understanding of essential bacterial proteins as a foundation for the future development of inventive antibiotics against important pathogenic bacteria such as Escherichia coli and Enterococcus faecalis. In addition, state-of-the-art biomedical electron paramagnetic resonance (EPR) spectroscopy instrumentation development will provide a transformative increase in research throughput that will enable a wide range of new applications including structural biology, metalloprotein research, redox biology, rational drug design, and clinical diagnostics for a range of human diseases.